Multidimensional cell recording with single-cell genomics

Abstract. A zygote - a single cell - successively divides to ultimately give rise to a highly organized mass of 40 trillion cells that constitutes an adult human. This complex cell lineage tree is shaped by genetic, molecular and environmental cues. Despite enormous progress over the past one hundred and fifty years ? how, when and where the decisions are made that determine the developmental lineage tree remain poorly understood for not only humans but nearly all multicellular organisms. Together with colleagues, I pioneered GESTALT (genome editing of synthetic target array for lineage tracing), a new technology based on in vivo genome editing during development that is capable of tracing cell lineage at the scale of whole animals. In our experiments to date, we have successfully captured the interrelated fates of hundreds of thousands of cells within a single organism, a critical step towards our eventual goal of globally mapping cell lineage in key model organisms. In this K99/R01 proposal, I describe how my lab will expand our initial proof-of-concept of GESTALT into a rich, flexible platform for biological recording, including molecular signals and cell lineage history in conjunction with transcriptomes, regulatory landscapes, and other measurements of single cell state. In the K99 phase of my award, I will enhance the information capacity of GESTALT system and further develop the requisite computational methods (Aim 1), and also integrate lineage recording with single cell transcriptional profiling (Aim 2). In the R00 phase of my award, I will expand GESTALT into a fully-fledged information recording platform, capable of recording key signaling events over the span of organismal development (Aim 3), and then apply this integrated platform to produce an annotated tree of brain development in Drosophila. The methods that I develop here will empower my lab, and the field at large, to answer long-standing questions about normal development as well as about the origins of diseases with complex etiologies rooted in cell lineage (e.g. cancer, developmental disorders).

Public health relevance
Project Narrative We all begin as an egg, who's fertilization precipitates a series of coordinated cell divisions, ultimately resulting in the forty million cells in each fully-formed human. How is this process regulated to constantly arrive at the correct final form? Here we propose to leverage single-cell genomics and recently developed lineage tracing technologies to record the cell divisions that make up an organism, capturing a family tree of development, onto which we can scaffold knowledge about regulatory factors, cell signals, and biochemistry into a more comprehensive view of normal development and its dysregulation in disease.